EFFECT OF IRBESARTIN IN HYPERTENSIVE PATIENTS WITH TYPE II DIABETES

The project will test the efficacy of irbesartan in reducing the rate of progression of renal disease and cardiovascular events in hypertensive patients with diabetic nephropathy due to Type II diabetes compared to patients treated with either the calcium channel antagonist amlodipine or placebo.